EPIDEMIOLOGY OF SLEEP DISORDERED BREATHING

The purpose of this study is to describe the natural history of sleep disordered breathing in the general population and to measure risk factors for, and health consequences of, sleep-disordered breathing.